Sex Differences in Endocannabinoid Regulation of Behavioral Flexibility

Project Summary
Around 30% of individuals who try drugs of abuse transition to addiction, suggesting that individual differences
prior to drug experience contribute to addiction vulnerability. Sign-tracking and goal-tracking phenotypes which
predict distinct drug relapse vulnerabilities, have been modelled in humans and rodents. Sign-tracking rats
show enhanced cue sensitivity prior to drug experience which predicts heightened cue-driven drug seeking and
increased cue-induced relapse as compared to goal-trackers. Men and women also differ in their addiction
vulnerability, where women show enhanced escalation of drug use and higher probability to relapse. Female
rats are more likely to be sign-trackers, suggesting a need to study sex differences in sign-tracking rats to
understand the unique neurobiological vulnerabilities in females. Sign-trackers and females are similarly
inflexible when rewarding outcomes are devalued. I have found that decreasing cannabinoid 1 receptors
(CB1R) signaling in the dorsomedial striatum (DMS) makes female sign-tracking rats flexible, but has the
opposite effect in male sign-tracking rats. CB1R are expressed on orbitofrontal cortex (OFC) inputs to the DMS
and on GABAergic interneurons and medium spiny neurons in the DMS. This project will focus on the
intersection of sex and sign-tracking, investigating DMS endocannabinoid regulation of behavioral flexibility. I
hypothesize that a CB1R-mediated decrease in OFC-DMS transmission prevents flexibility in female sign-
tracking rats, while a CB1R-mediated decrease in GABAergic transmission promotes flexibility of male sign-
tracking rats. First, I will use slice electrophysiology and RNAscope to understand the functional and
expression-based differences in CB1R within the DMS between male and female ST rats. Second, I will use
chemogenetics and slice electrophysiology to investigate the contribution of OFC-DMS projection to behavioral
flexibility and the influence of CB1R activation on this projection. Through these experiments, I aim to uncover
critical molecular and circuit-based mechanisms that contribute to impairments in flexibility that are associated
with addiction vulnerability.

Public health relevance
Project Narrative Addiction is a chronically relapsing neurobiological disorder that impacts both men and women but there are sex-specific patterns of drug use and relapse vulnerabilities in clinical and preclinical populations. Recent research suggests that individual differences before drug experience predict addiction vulnerability. To better understand the influence of sex on relapse vulnerability phenotypes, I propose to investigate sex differences in brain circuitry that is critical for sex- and phenotype-specific behavioral flexibility before drug experience.